Advanced Methods to Measure Sleep Spindle Coupling as a Key Neuroprotective Component of Slow Wave Sleep

Summary Per instructions https://www.nia.nih.gov/research/grants-funding/nia-diversity-and-re-entry-supplement- program-guidelines the summary is included in the 5 page research strategy.

Public health relevance
Narrative Narrative not required for this submission – see guidelines at: https://www.nia.nih.gov/research/grants- funding/nia-diversity-and-re-entry-supplement-program-guidelines